Molecular Targeted Radionuclide Therapy for Tumor Immunomodulation and Enhancing Immunotherapy Response

PROJECT SUMMARY ? ADMINISTRATIVE CORE The Administrative Core (Admin Core) provides the operational structure necessary for the planning, implementation and management of all P01 activities and promotes the efficient, progressive and successful conduct consistent with the program goals and P01 mission. It also provides administrative coordination, oversight and research support services to all leaders, co-leaders, investigators and core directors. By providing this support centrally, the Admin Core promotes efficiency and ensures that all P01 research and activities are focused and connected, complex scientific objectives are met, and existing cancer center resources are utilized and not duplicated. Finally, the Admin Core provides required project oversight, monitoring and auditing to ensure projects are meeting stated endpoints consistent with the P01 research plan and adhering to all regulatory requirements. An experienced, half-time administrative associate, Shari Piaskowski, will serve as the administrative manager of the P01, with support from institutional post award staff from University of Wisconsin central offices.

Public health relevance
PROJECT NARRATIVE - ADMINISTRATIVE CORE The Project Narrative is not required for the Administrative Core as per the PAR-18-290 Funding Opportunity Announcement.